Influence of fear conditioning prior to cocaine self-administration on cocaine seeking in adult rats: assessing the role of the frontostriatal circuits in trauma and cocaine use co-occurrence

PROJECT SUMMARY
Research has shown a high prevalence of trauma-related disorders and substance use disorder (SUD) co-
occurrence. However, the mechanisms by which a traumatic event increases the vulnerability to SUD
development and relapse are unknown. It is known that the prelimbic cortex (PL) and nucleus accumbens (NAc)
core play critical roles in trauma-related disorders and SUD, but the neurophysiological changes caused in these
structures by trauma and cocaine exposure are not fully understood. This proposal aims to dissect the
mechanism by which a traumatic experience and cocaine exposure alter PL and NAc core communication in
ways that may increase vulnerability to cocaine use disorder development. The hypothesis is that a traumatic
event and cocaine exposure will cause neurophysiological changes in PL-NAc core synapses, resulting in
increased drug-seeking behavior. To test the hypothesis, we will assess the effects of fear conditioning (FC) as
a traumatic event, and cocaine exposure on cocaine-seeking behavior in male and female rats. Also, we will
analyze the synaptic changes of the PL-projecting neurons to the NAc core, using whole cell patch-clamp
electrophysiological recordings with optogenetic manipulation (Aim 1), as well as the influence of PL inactivation
on cocaine seeking (Aim 2) from cocaine-exposed rats with or without FC. Preliminary behavioral data show that
FC prior to cocaine exposure increases cue-primed reinstatement and cocaine-primed reinstatement in male
rats, providing a suitable behavioral paradigm for investigating the neurophysiological changes that occur in this
comorbidity. The findings of the proposed study will provide insight into how PL modulates the NAc core neurons
in the presence of a traumatic experience and drug exposure, to influence drug-seeking behavior.

Public health relevance
PROJECT NARRATIVE The proposed study has considerable relevance for public health as it will elucidate the neurophysiological mechanisms that cause individuals with substance use disorder and trauma-related disorder comorbidity to have poor adherence to treatment and high relapse rates and accordingly, it may ultimately aid in the development of effective therapies. This project aims to elucidate the effects of fear conditioning and cocaine exposure on prelimbic cortex modulation of nucleus accumbens core neurons, concerning drug-seeking behavior in a rat model. Understanding how trauma-related disorders and SUD comorbidity alters the communication within this circuitry may provide the basis for developing new pharmacological interventions that could reduce cocaine relapse.